Metabolic modulation of Fusobacterium nucleatum virulence

PROJECT SUMMARY
Fusobacterium nucleatum, a Gram-negative anaerobe that plays a key role in the development of oral biofilms,
or dental plaque, has the remarkable ability to escape host immunity and spread to extraoral sites, including
placenta and colon, where it is associated with significant diseases such as preterm birth and colorectal cancer.
To date, we have a poor understanding of the mechanisms of virulence and disease by F. nucleatum, and the
environmental factors in the extraoral sites that potentially affect the virulence potential of this pathogen.
Considering that ethanolamine (EA) – an important source of carbon/nitrogen and energy, and a signaling
molecule for some bacterial pathogens – is abundant in placenta during fetal development, we aim to test the
central hypothesis that regulated EA metabolism via a specialized organelle, bacterial microcompartment (BMC),
modulates the virulence potential of F. nucleatum. This hypothesis is based on our compelling preliminary data
showing that environmental EA stimulates BMC formation and expression of EA utilization genes, and that
blockage in EA catabolism alters the pathogenicity of F. nucleatum. The major goal of this application is to
examine how BMC-mediated EA utilization affects fusobacterial virulence (Aim 1) and how blockage in EA
catabolism modulates fusobacterial pathogenicity (Aim 2). The results generated from our studies will not only
provide important knowledge regarding the pathophysiology of F. nucleatum and promising therapeutic targets,
but also have potential to advance the broad field of host-pathogen interactions.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT This study will examine how metabolism within specific host organs and the resulting metabolites within those host environments affect the virulence potential of Fusobacterium nucleatum, a key colonizer in the development of dental plaque and a pathogen linked to both pre-term birth and colorectal cancer. A better understanding of these host-pathogen relationships is needed to unveil critical new targets for developing anti-infective therapies so as to treat and prevent significant diseases that are associated with this pathogen.